Leveraging telehealth to optimize PrEP and PEP delivery at pharmacies in Kenya

ABSTRACT
Highly effective HIV pre- and post-exposure prophylaxis (PrEP and PEP) have been available at public HIV
clinics in Kenya for almost a decade; however, limited opening hours, long wait times, and HIV stigma at clinics
have hindered uptake and consistent use of these interventions, thus attenuating their impact on population-
level HIV incidence. To increase PrEP/PEP use, the Kenya Ministry of Health (MOH) is interested in expanding
delivery to new settings, including private community pharmacies. Our research team recently completed two
prospective pilot studies in Kenya to test a novel delivery model in which trained pharmacy providers initiate and
manage clients on PrEP and PEP under remote clinician supervision (NIH R34 MH120106, PI: Ortblad; BMGF
INV-033052, MPIs: Ortblad/Bukusi/Ngure). This model reached PrEP- and PEP-eligible individuals and was
highly acceptable to providers and clients; however, two key implementation challenges emerged: the heavy
time burden on pharmacy providers and suboptimal continuation among clients. To understand whether
introducing a remote nurse to assist with delivery and provide client support improves clinical and implementation
outcomes, we propose conducting a hybrid effectiveness-implementation cluster-randomized controlled trial at
20 pharmacies in Kisumu and Homa Bay Counties (Western Kenya). In Aim 1, we will 1:1 randomize 20
pharmacies (n=1,580 clients ≥15 years) to either: 1) telehealth support, where a remote nurse screens, counsels,
and guides clients through HIV self-testing (HIVST) and, between visits, communicates with interested clients
via 2-way SMS, or 2) standard delivery, where the pharmacy provider performs all delivery tasks and clients are
not given additional support. Our primary outcomes will be PrEP/PEP initiations and continuation by 6 months;
secondary outcomes will include reach, visit duration, product mix, product switching, and PrEP adherence. In
Aim 2, we will evaluate intervention acceptability and feasibility and identify implementation barriers and
facilitators using a sequential explanatory mixed methods approach that integrates Aim 1 quantitative findings
with qualitative data from routine technical assistance reports, de-identified SMS transcripts, and in-depth
interviews (n=81) with clients, pharmacy providers, remote nurses, and key stakeholders. In Aim 3, we will
estimate the intervention’s cost-effectiveness and budget impact. In line with recent World Health Organization
recommendations, this study will use HIVST to support PrEP delivery and enable client choice by offering
multiple types of biomedical HIV prevention products (e.g., daily oral PrEP; on-demand PrEP; PEP). This study
will be the first to leverage telehealth for PrEP/PEP delivery in brick-and-mortar pharmacies in Kenya; if found
effective, this model has high potential to inform PrEP delivery guidelines in Kenya and other settings where
private pharmacies are numerous and highly accessed, but staff typically do not offer services beyond
dispensing. Our teams’ extensive experience conducting HIV implementation research in collaboration with the
Kenya MOH and our support from national pharmaceutical organizations will ensure the success of this project.

Public health relevance
PROJECT NARRATIVE Several recent pilot studies have demonstrated high reach, uptake, and acceptability of HIV pre- and post- exposure prophylaxis (PrEP and PEP) services when made available at private pharmacies in Kenya; however, the heavy time burden on pharmacy providers and low PrEP/PEP continuation among clients threaten the scale- up and impact of this approach. In this study, we will evaluate whether introducing a remote nurse to screen, counsel, and guide clients through HIV self-testing (via a telehealth platform) and support interested clients (via SMS) between pharmacy visits increases PrEP/PEP initiations and continuation compared to standard PrEP/PEP delivery by pharmacy providers. We hypothesize that pharmacy PrEP/PEP services delivered with telehealth support will result in better service utilization and implementation outcomes compared to standard delivery and be cost-effective to implement.